Enhancing Vet-LIRN antimicrobial resistance surveillance activity through collection of AMR data for 720 and whole genome sequencing (WGS) of 300 bacterial isolates from five Canadian provinces

Project abstract summary Since acquisition of an Illumina MiSeq (October 2018), the Animal Health Laboratory (AHL) has been working on established a Canadian veterinary diagnostic laboratory unit (5 source labs and 1 WGS regional lab) to support and expand the Vet-LIRN Antimicrobial Resistance-Whole Genome Sequencing (AMR-WGS) initiative. In order to enhance the Vet-LIRN capacity and capability for AMR-WGS, we are planning to focus our work in 2019 on 2 main research objectives: 1. To establish a fully functional network of source laboratories that will: a. Collect bacterial isolates for WGS and provide AMR data to Vet-LIRN. b. Ship isolates quarterly to the AHL for WGS. c. Provide accurate and thorough metadata information for all isolates. 2. To establish AHL as a WGS regional laboratory that will: a. Do WGS of bacterial isolates submitted by the source labs as per AMR-WGS Vet-LIRN initiative. b. Obtain GenomeTrakr certification for WGS by regularly participating in proficiency testing (PT) provided by GenomeTrakr. c. Participate in any additional PT activities as required. d. Be the main point of contact between Vet-LIRN and the source laboratories. e. Organize isolate receiving and storage for the purpose of WGS. f. Make sure that metadata and AMR information will be transferred to Vet-LIRN. g. Submit WGS results to GenomeTrakr to provide public access to it.

Public health relevance
Project narrative In November 2018, a Canadian veterinary diagnostic laboratory unit was established to work on the Vet-LIRN AMR-WGS initiative. It is comprised of 5 major provincial diagnostic laboratories located in Ontario (AHL), Saskatchewan (PDS), Quebec (MAPAQ), Prince Edward Island (AVC), and Manitoba (VDS) (letter of understanding from each lab attached). Similarly to our USA counterparts, there are 5 source laboratories tasked to collect bacterial isolates for WGS, to provide antimicrobial susceptibility data to Vet-LIRN and also to provide accurate and thorough metadata information for all isolates collected. Isolate collection, naming rules, and metadata sheets were provided to all labs in January 2019. After a relatively slow start due to the USA government shutdown, our source laboratories are getting up to the full speed now with routine collection of isolates. The AHL has isolates from 2 labs for the first quarter (that includes AHL isolates) and are gearing up to receive isolates for the second quarter (in July). All source labs participated on a Vet-LIRN conference call and were provided additional information on metadata collection. We are anticipating that by the end of this calendar year all of the labs will be up to speed with metadata recording. Four source labs are using automated systems for antimicrobial susceptibility reading, and transfer of this information to Vet-LIRN should be straightforward. One of the labs is still doing manual readings, but are looking into purchasing BioMic automated reader for their disk diffusion plates. It has been forecast that by the end of 2019 we will have a fully functional network of source labs that will require very little coaching but will need some financial support to offset the cost of equipment and supplies and potentially some labour cost for data and isolate collection and shipping. In contrast to other USA Vet-LIRN AMR-WGS labs, our AHL lab has been playing a dual role within the Canadian unit. As we already have 2 y of experience in isolate collection and are one of the biggest veterinary labs in Canada, we are continuing with our source lab role as specified above. On top of that and as a result of Illumina MiSeq acquisition, we are planning on establishing AHL as the first Canadian WGS Vet-LIRN laboratory to enhance capacity and capability of the Vet-LIRN AMR-WGS initiative. Because of the USA and Canada geographic location, there is a constant movement of animals and animal products and by-products across the border and it is important to monitor disease and AMR trends on both sides. To monitor these trends, it is of critical importance to use harmonized analytical methods and to support training and provide proficiency evaluations for them. As a part of our plan to establish the AHL as a WGS lab we started with a manufacturer's provided training for MiSeq, and to enhance the capability of the lab, we had 4 people attend that training. Our capability was further increased by hiring a full-time technician dedicated to work on WGS of bacterial isolates submitted by source labs. To increase the AHL capacity, basic tools for WGS analyses, including BaseSpace professional account and BioNumerics software, were purchased. To ensure our proficiency in WGS we have already run 2 sets of test samples provided by Vet-LIRN and are currently in the process of preparing for proficiency sample testing (PT) provided by GenomTrakr as it is our goal to get GenomeTrakr certification for WGS before we start working on WGS of Vet-LIRN isolates. Once GenomeTrakr PT is passed, we will start WGS of Vet-LIRN isolates and transferring data to GenomeTrakr for public assess. For the duration of the project, the AHL will also be the main point of contact between Vet- LIRN and the source labs to help with isolate and metadata collection and transfer of information. In summary, this work will increase the capacity and capability of the Vet-LIRN AMR-WGS initiative while establishing and expanding our international partnership.